K23 Resubmission - Impact of adoptive T cell therapy on immunity to SARS-CoV-2 after bone marrow transplant

The overarching goal of this proposal is the development of the candidate into an independent investigator in
the field of immune modulatory cell therapy for critically ill children, particularly those post hematopoietic stem
cell transplant (HSCT). With her clinical and research background in pediatric critical care and T cell
immunotherapy, she is ideally positioned to fully realize the benefits of an NIH Mentored Career Development
Award. This research proposal seeks to establish the safety and preliminary efficacy of adoptive immunotherapy
with donor-derived SARS-CoV-2-specific T cells (CST) for prophylaxis against SARS-CoV-2 infection in patients
post HSCT by conducting an FDA- and IRB-approved phase I clinical trial (NCT 05141058) and to develop CSTs
genetically engineered to maintain antiviral activity in the presence of the commonly used lymphodepleting agent,
alemtuzumab. The specific aims of the proposal are: 1) to determine whether infusion of donor-derived CSTs
safely enhances antiviral immunity to SARS-CoV-2 in patients early (<4 months) post HSCT, and 2) to genetically
engineer CSTs to retain antiviral activity in vitro in the presence of alemtuzumab. Together, these aims will
establish the safety and preliminary efficacy of CST prophylaxis in the post HSCT population and lay the
foundation for a “next generation” of virus-specific T cells (VST) engineered to resist immunosuppressive peri-
transplant drugs. In addition, they will develop the candidate's expertise in T cell immunobiology, high throughput
sequencing, gene editing, and early phase clinical trials. The candidate has assembled an outstanding advisory
team who are highly qualified to guide her in the pursuit of her career and research goals. Her primary mentor
and co-mentor, Drs. Catherine Bollard and Michael Keller, are world-renowned experts in immune modulatory
cellular therapy and T cell immunobiology. Dr. Matthew Porteus, a pioneer in the field of gene therapy, will guide
her work developing genetically engineered CSTs. In addition, Dr. Patrick Hanley, Director of the Good
Manufacturing Processes Laboratory at Children's National Hospital, will oversee production of the CST product
(IND 27588); Dr. Rick Jones will advise and oversee trial conduct at Johns Hopkins Medical Institutions (JHMI);
and Dr. Wei Li will provide bioinformatic support for both CRISPR and high throughput sequencing experiments.
A selection of focused coursework and seminars will facilitate investigator independence by the end of the award
period. The candidate will benefit from a superb academic environment and extensive resources available
through the Center for Cancer and Immunology Research, the Genetic Medicine Research Center, and the
Clinical and Translational Science Institute at Children's National, as well as from in-person training in gene
editing in the Porteus laboratory. In summary, this proposal describes a plan that is relevant, feasible, and will
provide the necessary mentorship and training to promote the candidate's development into an independent
clinician scientist in the field of cellular immune modulatory therapy.

Public health relevance
PROJECT NARRATIVE The proposed research will study whether infusions of T cells targeting the SARS-CoV-2 virus are safe and effective in restoring immunity in patients who have undergone bone marrow transplant. It will additionally study ways to produce T cells targeting SARS-CoV-2 that will function even in the presence of immunosuppressive drugs that interfere with T cell function. This application outlines an experimental plan, mentorship team, and targeted didactics that will provide the candidate with the experience and support needed for her to attain graduated research independence by the end of the award period.